Single-Cell Transcriptional and Epigenomic Dissection to Identify Therapeutic Targets for ALS and FTD

Abstract
Frontotemporal lobar degeneration (FTLD) and amyotrophic lateral sclerosis (ALS) are devastating and fatal
neurodegenerative diseases that strike middle-aged adults just as they reach full familial, financial and career
potential. Initially thought to be quite distinct, FTLD and ALS are now recognized to share many clinical,
pathological, and genetic signatures, but the mechanistic basis of their shared and distinct circuitry remains
unknown at the molecular level. Genome-wide association studies (GWAS) have uncovered multiple common
weak-effect variants, but the vast majority are non-coding, making it difficult to identify their target genes and
the cell types where they act. To address this challenge, in Aim 1, we systematically profile the transcriptional
and epigenomic alterations of FTLD and ALS patients at single-cell resolution using post-mortem brain
samples. In Aim 2, we integrate the resulting datasets to study the link between genetic, epigenomic,
transcriptional, and cellular signatures of FTLD and ALS, and to study the common and distinct genes and
pathways altered in each, to predict new therapeutic targets. In Aim 3, we validate the molecular and cellular
effects of these targets using high-throughput directed perturbation experiments and both cell-autonomous and
non-autonomous phenotypes guided by our predicted pathways, and we disseminate all our results to the
community. The resulting datasets, analyses, and validated targets will provide an invaluable resource to
understand the mechanisms of action of FTLD and ALS, and the common and unique circuitry towards new
therapeutic targets.

Public health relevance
Narrative Amyotrophic lateral sclerosis (ALS) and frontotemporal lobar degeneration (FTLD) are two devastating and fatal neurodegenerative disorders that are clinically distinct but show an overlap in brain pathology and genetic factors, but the mechanistic basis of their shared and distinct circuitry remains unknown at the molecular level, which prevents the identification of needed therapeutic targets. Here, we use single-cell high-resolution profiling of epigenomic and transcriptional alterations in post-mortem brain samples from ALS and FTLD patients to elucidate their underlying mechanism of action, shed light on their common and distinct circuitry, bridge the gap between genetic variation and highly polygenic complex traits in ALS and FTLD, and identify new therapeutic targets for these devastating disorders.